IGF::OT::IGF SUPPORT SERVICES, STRATEGIC PLANNING, CONSULTATION AND WRITING SUPPORT PROVIDED BY PR STRATEGISTS, LLC:1153323 [16-054728]

Provided needed scientific support services, strategic planning and consultation to the NCI